From Crest to Bone: Understanding neural crest skeletogenic capacity along the neural axis

ABSTRACT
The evolution of vertebrates has been significantly shaped by the emergence of the neural crest, a critical
innovation believed to have bolstered predatory prowess and fostered the expansion of craniofacial structures.
During development of vertebrate embryos, distinct neural crest subpopulations arise along the body axis. While
these subpopulations share a basic neural crest gene regulatory network (GRN), superimposed upon this are
distinct regional subcircuits that imbue subpopulations with distinct developmental potentials. Indeed, only the
cranial neural crest in amniotes possesses the ability to generate ectomesenchymal derivatives like osteoblasts.
Recent studies have demonstrated that axial level specific GRN subcircuits play a critical role in enabling neural
crest cells to develop specific cell types, with amniotes possessing a cranial-specific circuit capable of
reprogramming trunk neural crest cells to form craniofacial cartilage. In our recent research, we discovered that
trunk neural crest cells in sturgeons, a primitive group of bony fish, possess the remarkable ability to create bony
structures in the postcranial region, suggesting that the ancient neural crest has the ability to contribute to the
formation of skeletogenic tissues along the entire neural axis. By utilizing this unique model organism that has
dermal bones from head-to-tail, my goal is to undercover the underlying fundamental GRN driving neural crest-
derived bone formation. I hypothesize that this basic GRN may have served as a scaffold that became elaborated
and increased in complexity during vertebrate evolution, culminating in craniofacial bone formation in mammals.
This proposal will determine the presence of genes akin to amniote "cranial-specific" gene regulatory
circuit in sturgeon. To investigate this, hybridization chain reaction and CRISPR/Cas9-mediated mutagenesis
will be used to examine coexpression and linkages within the GRN subcircuits in migrating neural crest cells and
their derivatives. Next, single cell RNA-sequencing and unbiased comparative transcriptomic analysis will be
performed on sturgeon neural crest cells at cranial and trunk levels and compared with chick and lamprey
datasets to uncover genetic circuits characteristic of sturgeon neural crest subpopulations, particularly those
associated with skeletogenesis. Finally, ATAC-seq assays at various axial levels and developmental stages
during sturgeon neural crest development will be used to pinpoint potential enhancers and assess alterations in
open chromatin patterns based on axial location and developmental timing. Together, the results of these aims
will illuminate the mechanisms underlying the origin of new cell types, such as osteoblasts, within the neural
crest. In addition to identifying useful targets for therapeutic intervention preventing craniofacial defects, this
award will provide me with necessary training as I prepare to begin my independent career. Dr. Marianne
Bronner's laboratory at the Caltech and the assembled advisory council offer essential resources, knowledge,
and training atmosphere required to effectively pursue the proposed objectives and help me establish an
independent research career.

Public health relevance
PROJECT NARATIVE Studying the molecular mechanisms that drive neural crest stem cells to differentiate into bones is of critical importance due to its implications for developmental disorders like retrognathia and cleft palate, as well as neural crest-derived cancers like neuroblastoma, which may invade bones. The proposed project investigates neural crest-derived bone development in a unique model system that resembles the ancestral/basal type of neural crest-derived osteogenesis. Thus, the results of this proposal will provide important insights into molecular mechanisms crucial for normal neural crest-derived bone development and maintenance, including head skeleton.